NeuroMAP Phase II - Administrative Core

PROJECT SUMMARY: Administrative Core
The Administrative Core for Neuroscience-based Mental Health Assessment and Prediction (NeuroMAP)
CoBRE will continue to provide the following specific aims: (1) infrastructure for programmatic development
and oversight; (2) an integrated training and mentoring plan for Research Project Leaders (RPLs); (3)
operational support of RPL and Pilot Project Investigator (PPI) day-to-day operations; and (4) management of
the Pilot Project program. The basic premise of NeuroMAP Administrative Core is that a supportive framework
is necessary to create a strong, interdisciplinary, translational team of junior investigators to transition to R-
level competitive researchers. NeuroMAP Phase I Administrative Core accomplishments facilitated by the
strategic/scientific oversight of the Leadership Team and Advisory Committee (AC) include: (1) the foundation
of a supportive base and training platform for five RPLs during Years 1-3, three RPLs during Years 4-5, and
eight PPIs; (2) successful matching of External Mentors with extensive R01-level funding experience to RPLs
to facilitate career development; (3) four funded R01s by NeuroMAP investigators (two RPLs and two PPIs)
and 14 grant applications submitted by PPIs; (4) active integration of NeuroMAP into the local academic
community via participation from Oklahoma State University, University of Oklahoma, and University of Tulsa
faculty; and (5) successful recruitment of junior investigators to apply for Pilot Projects. During Phase I, the AC
made various suggestions to improve NeuroMAP Phase II, which included: (1) tighter focus on grants that can
be applied for based on RPL data; (2) increased statistical consultation; (3) expanding biological assessments
beyond neuroimaging; (4) consideration of local mentors for RPLs and PPIs. As a result, Phase II adds the
following infrastructure developments: (1) past NeuroMAP RPLs and PPIs who earned R01-level funding will
now serve as Internal Mentors to current RPLs; (2) availability of Phase I NeuroMAP multilevel Core data
(neuroimaging, behavior, questionnaires, clinical assessments) for new Pilot Projects, thereby facilitating
hypothesis testing for future R01 grant applications; (3) successful recruitment of Dr. Wesley Thompson, a
statistician with a successful track record of R01-level funding who will guide RPLs and PPIs in data analysis
planning/execution; and (4) expansion of training opportunities to include research involving blood-based
biomarker and genetic data processing and analysis. Accomplishing these aims of the Administrative Core will
extend the critical mass of independent investigators necessary for the theme of NeuroMAP to continue to
receive NIH funding and identify new treatment targets to reduce the personal, financial and societal burden of
mood and anxiety disorders.